Data Management and Statistics Core

PROJECT SUMMARY/ABSTRACT: DATA MANAGEMENT AND STATISTICAL CORE
The Data Management and Statistical (DMS) Core of the Goizueta Alzheimer’s Disease Research Center
(GADRC) at Emory manages and analyzes the vast amounts of data generated by the Center’s research
activities, disseminating to investigators within and outside the GADRC and to the National Alzheimer’s
Coordinating Center (NACC). This facilitates cutting-edge research addressing the heterogeneity of
Alzheimer’s disease (AD) and AD related dementias (ADRD), enabling precision in early detection and
intervention. The DMS Core plays a crucial role in the GARDC activities by providing infrastructure and
expertise in data management and harmonization, methods development, statistical analysis, and results
interpretation. It unifies all Cores by linking data collection efforts, providing a platform and tools for advanced
analytics, and acting as a conduit for these efforts at all levels. During the current funding period, the GADRC
DMS Core has been extremely successful in achieving its goals, supporting data collection, integrating new
data sources, facilitating data sharing, collaborating on grants and publications, and developing innovative
methods to characterize AD/ADRD heterogeneity.
In the next funding cycle, the DMS Core will achieve the following aims: (1) To continue to maintain a
scientifically rigorous research database and analytics tools that support NACC, the GADRC Cores,
developmental projects, local investigator-initiated studies, Research Education Component trainees, and
national collaborative studies; (2) To provide statistical consulting and collaboration on the design, conduct,
analysis and interpretation of GADRC-related studies and grants; and (3) To develop innovative methods to
support research on mixed etiology dementia, focusing on multi-modal data integration for subtype discovery in
AD/ADRD, statistical methods to classify heterogeneous samples of patients into clinically relevant subgroups,
and the application of artificial intelligence/machine learning tools to analyze data from the GADRC and its
linked cohorts. By leveraging and integrating Core activities and expertise with other GADRC cores and related
initiatives across Emory, the DMS Core will facilitate cutting-edge research to advance the field of AD/ADRD.